IONIC HOMEOSTASIS IN ANOXIC CARDIAC MUSCLE CELLS

DESCRIPTION this project is to analyze the basic mechanisms by which cell injury occurs in anoxic cardiac muscle. The project will use anoxic guinea-pig ventricular myocytes as the experimental model, and is designed to test the overall hypothesis that the irreversible hypercontracture seen upon reoxygenation is a result of a dynamic and interactive imbalance between cytosolic [Ca2+] and pH, and mitochondrial function. In order to test this hypothesis, the project is organized around the following specific aims. 1) Analyze the relative contributions that the Na+ channel, the Na+/H+ exchanger, and the Na+/K+ pump make to the elevation of [Na+] during anoxia. 2) Test the hypothesis that the reoxygenation-induced Ca2+ spike is caused by the recovery of the Na+/Ca2+ exchanger from inhibition. 3) Determine whether enhanced mitochondrial Ca2+ accumulation early in reoxygenation is beneficial to the cell by significantly lowering cytosolic [Ca2+], or injurious, by causing significant mitochondrial depolarization. 4) Test the hypothesis that the cytosol becomes acidic enough during reoxygenation to retard the onset of hypercontracture, and that the time-course of recovery from acidification is an important factor in determining cell survival. The effects of anoxia on cytosolic [Ca2+], [Na+], and pH will be studied using fluorescent indicators. The effects of anoxia on the Na+/Ca2+ exchanger and the Na+ channel will be studied with the patch-clamp technique. Finally, mitochondrial membrane potential and [Ca2+] will be measured using confocal fluorescence microscopy.